Understanding Cardiovascular Disease Mechanisms

ABSTRACT
This is a second renewal application for a pre- and postdoctoral training program, the title and theme of which is “Understanding Cardiovascular Disease Mechanisms”. The University of Cincinnati and Children’s Hospital has a renowned legacy spanning more than 4 decades of previous NIH T32 support for cardiovascular study, and this current T32 represents the only CV program in Cincinnati. In the past 4 years of this program covered by the renewal application, our 16 trainees published 34 papers and 6 received independent grant funding during their support period, while 5 graduates have matriculated to jobs in scientific careers. The overall scientific emphasis of our training program will continue to build from a basic platform of cardiovascular physiology, cell biology, biochemistry and pharmacology, but will also incorporate the latest approaches in biomedical research, as well as incorporating clinical and translational approaches. The cardiovascular environment at Cincinnati Children’s and the University of Cincinnati is considered one of the very best in the country. Our 20 current training grant faculty are all NIH funded (some 66 NIH funding components amongst them as PI status) with 166 collaborative papers published together, and all are employing the very latest technologies and approaches with outstanding institutional core support. The leadership consists of the co-PIs Drs. Evangelia Kranias and Jeffery Molkentin, both of whom have a long track record of working together (24 years), as well as having excellent mentorship credentials. The Executive Committee (2 members), Internal Advisory Committee (4 members) and External Advisory Committee (3 members) are highly engaged cardiovascular researchers who will continue to help ensure the quality of the training program. The renewal requests continuation of the funding of 3 pre- and 3 postdoctoral trainee positions. Predocs are selected by the Internal Advisory Committee from a vast and outstanding pool of candidates amongst 9 departmental graduate programs, while postdoctoral candidates are selected based on being accepted into a mentor’s laboratory and then passing the screening process by the Internal Advisory Committee and co-PIs. The mentoring program and evaluation process for the program are highly structured and oversight occurs on many levels. Trainees and mentors are evaluated every 6 months with IDPs and committee meetings. The proposed educational training curriculum is highly structured and state-of-the-art.

Public health relevance
PROJECT NARRATIVE Heart disease remains the leading cause of death and disability in the western world. This proposed renewal training grant application will again focus on a theme that addresses this medical problem, and our collective 20 faculty members have made this their life's work. The program will train the highest quality of young scientists in cardiovascular research, who will be the future leaders in developing better therapy and treatment for this devastating condition.